Development of a screening diagnostic for the detection of viruses and bacteria from body fluids that utilizes the unparalleled structural characterization of mass spectrometry

Project Summary/Abstract
The long-term goal of this project is to develop of a rapid, inexpensive, and sensitive screening
diagnostic based on an innovative broad proteomic approach to improve our ability to diagnose
infectious disease, monitor changes in the microbiome, measure the state of the host immune system,
and identify disease specific biomarkers. Specifically, the initiative will provide proof of principle for a
method to achieve simultaneous multi-pathogen detection and deep proteomic microbiome
characterization. We will work to detect the presence of several hundred pathogens while also
identifying thousands of microbes at clinically relevant levels. The short amino acid sequences or
peptides from the proteins will provide markers that range from the virus variant level, such as SARS-
CoV-2 variants of concern, to the family level, such as coronaviridae. In developing this diagnostic, a key
challenge is to maximize the sensitivity of peptide marker detection while analyzing for many clinically
relevant viruses and bacteria. We will therefore compare the performance of (a) a data-dependent
acquisition method that searches a custom database and (b) a data-independent acquisition method
that can identify thousands of proteins. The proposed study will begin with the analysis of
approximately twenty model pathogens before proceeding to the more ambitious analysis of more than
230 oro-respiratory samples. We will assess the primary factors that determine the performance of each
method and use our milestones to select one approach for further development. In the end, this
research will demonstrate the feasibility of a broad protein-based screening diagnostic that can detect
numerous pathogens and provide microbiome profiling to ultimately improve the diagnosis of disease
and assessment of human health. The project team includes researchers with diverse expertise from
Penn Engineering, Microbiology, and Penn Medicine.

Public health relevance
This application seeks to develop broad scanning medical diagnostic method for the detection of numerous pathogenic viruses and bacterial while characterizing microbiome of oral fluids. This diagnostic approach will improve healthcare by enabling early detection and more detailed profiling of both pathogenic and commensal microorganisms from human body fluids.